NAD-dependent Signaling and Pulmonary Vascular Remodeling in PAH

PROJECT SUMMARY
RATIONALE: Pulmonary vascular remodeling is a pathological feature of Pulmonary Arterial Hypertension
(PAH) that ultimately leads to death. Pulmonary Arterial Endothelial Cells (PAECs) are critical regulators of
pulmonary artery homeostasis. During PAH, PAECs undergo metabolic changes (Warburg effect) and PAECs
dysfunction that leads to a pro-proliferative and apoptosis-resistant phenotype that causes Pulmonary Vascular
Remodeling. Current therapies targeted at the vasomotor tone and inflammatory regulators have improved
prognosis, however, do not remedy vascular remodeling. Nicotinamide phosphoribosyltransferase (NAMPT) is
the rate-limiting protein in NAD+ synthesis. NAMPT overexpression upregulates glycolysis, promotes pulmonary
vascular remodeling, and contributes to PAH pathobiology. The Loss or pharmacological inhibition of NAMPT
attenuates PH in animal models, indicating its therapeutic potential. However, there is a gap in our understanding
of the cellular mechanisms by which NAMPT promotes PAECs dysfunction and pulmonary vascular remodeling.
Sirtuin3 (Sirt 3), an NAD+ dependent deacetylase enzyme involved in mitochondrial homeostasis, has been
implicated in PAH, as Sirt 3 KO mice were shown to develop experimental PH. Based on these observations,
we hypothesize that in the glycolytic environment characteristic of PAH, Nampt in human PAECs (hPAECs)
impairs Sirt 3 function to cause a metabolic reprogramming mediated PAEC dysfunction, and vascular
remodeling. METHODS: To investigate the hypothesis, NAMPT, an appropriate control, and a NAMPT construct
lacking enzymatic activity will be overexpressed in hPAECs using lentiviral particles at 20 MOI for 24hrs. This
model is advantageous as it ensures stable gene expression and further experimentation. Experiments proposed
in AIM 1 will permit the evaluation of NAMPT in regulating the function of SIRT3/SOD2 (Manganese-dependent
Superoxide Dismutase) axis to promote hPAECs dysfunction. The evaluation will be performed using seahorse
metabolic assay, mitochondrial membrane potential assay, oxidative stress assays, SIRT 3 activity assay, and
SOD2 activity assay. AIM 2 will address how NAMPT leads to the metabolic reprogramming of PAECs in vivo
to promote PAH. Conditional NAMPT EC (Endothelial Cell) overexpressing (OE) mice and conditional NAMPT
EC deficient mice (KO) models will be utilized. Hemodynamic studies assessing pulmonary artery remodeling,
right ventricular hypertrophy, and right ventricular systolic pressures will be performed, and harvested PAECs
subjected to metabolic and SIRT3 activity assays. CONCLUSIONS: These studies when completed will help
show that NAMPT overexpression can promote endothelial dysfunction via Sirt3 activity inhibition, resulting in
an increase in SOD2 acetylation which could lead to increased reactive oxygen species (ROS) production,
promoting vascular remodeling and PH pathogenesis.

Public health relevance
PROJECT NARRATIVE Pulmonary vascular remodeling is a critical hallmark of Pulmonary Arterial Hypertension. Nicotinamide phosphoribosyltransferase (NAMPT) has been shown to promote pulmonary vascular remodeling, and its inhibition can be a potential therapeutic target. The proposed research will seek to elucidate cellular and metabolic mechanisms governing how NAMPT contributes to PAH pathobiology via metabolic reprogramming mediated pulmonary vascular remodeling.